Training Program in Pharmacology

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The overarching goal of this predoctoral Training Program in Pharmacology (TPPh) is to educate next
generation of biomedical researchers in the concepts of drug discovery and development, including a
clinical perspective. The four focus areas of this TPPh are cardiovascular, neurological, and immunological
diseases and cancer. UC Davis is a world leader in drug development with multiple trainers bringing drugs
to the clinic (most recently Dr. Rogawski the novel post-partum antidepressant Brexanolone) and biologics
including gene therapy vectors with >20 ongoing clinical trials (Director Dr. Nolta). Trainees from
Pharmacology & Toxicology, Physiology, Biomedical Engineering and Neuroscience develop expertise in
various scientific areas. This reaches from classic pharmacology & drug target identification with cutting edge
methods in biochemistry, structural biology, genomics & proteomics, molecular and cell biology, high &
superresolution imaging, electrophysiology, and behavioral physiology, to in silico structural modeling and
rational drug design, medicinal chemistry, engineering of microfluidic and other devices, animal models of
disease, novel in vivo whole animal imaging and translational therapeutics in clinical trials including stem cell
and genetic therapies. The TPPh will provide focused and student-tailored small group training in the core
principles of pharmacology for non-pharmacology trainees, and enmesh these students with pharmacology
students for interdisciplinary group learning in drug development. A related goal is to enable all trainees to
communicate and collaborate across the large array of research disciplines they represent. This goal is mainly
realized in a highly innovative student-driven, project-oriented course Problem Solving in Pharmacological
Sciences, which reinvents itself every year based on student initiative and interest. In this way our TPPh
produces experts with a variety of backgrounds that can effectively communicate and collaborate with experts
from other related disciplines in the increasingly complex realm of drug development. UC Davis grants more
bachelors and doctoral degrees in biological sciences than any other U.S. university. It received $941 million in extramural research funding in 2019/20, which places it, as in earlier years, among the top 10 public
universities. The 32 training faculty are from 14 departments in 6 colleges, where extensive collaborative
interactions already exist. Trainers provide in depth expertise that ranges from identifying novel therapeutic
molecular targets and development of therapeutic molecules to clinical drug and stem cell trials at the NIH funded UC Davis Clinical and Translational Science Center (CTSC) and NIH-designated Cancer Center.
Powerful and numerous state-of-the-art core facilities and centers will provide trainees with outstanding
research opportunities spanning from Chemistry’s emphasis on pharmaceutical chemistry to unique animal
models (internationally recognized mouse biology center, Agricultural & Veterinary Schools, Primate Center).

Public health relevance
TRAINING PROGRAM IN PHARMACOLOGY Project Narrative (Public Health Statement) The Training Program in Pharmacology at UC Davis provides unique training in drug discovery and development to educate future biomedical researchers, who will be involved in the creation of novel therapeutic treatments of diseases in various areas. It builds on the existing strengths in the interdisciplinary collaborative research and training environment at UC Davis, where training program faculty have developed and clinically test new drugs and other therapeutics and diagnostics. It will train predoctoral PhD students in pharmacology and foster interdisciplinary training and research collaborations in drug discovery and development for graduate students in Pharmacology, Neuroscience, Physiology, and Biomedical Engineering graduate programs. A combination of formal and informal research training experiences will provide trainees with an understanding of how basic and clinical sciences are integrated to translate therapeutic target discovery to drug development, screening, mechanistic preclinical and clinical studies.